Dysregulation of sphingolipid metabolism and signaling in LAM

Project Summary Abstract
Lymphangioleiomyomatosis (LAM) is a devastating rare lung disease almost exclusively affecting young women.
LAM is characterized by smooth muscle cell growth and emphysema-like lung destruction. LAM is associated
with mutations in the TSC2 resulting in activation of the mechanistic target of rapamycin complex 1 (mTORC1).
Although the mTORC1 inhibitor, Sirolimus, stabilizes lung function and improves symptoms in some LAM
patients, lung function declines after drug discontinuation and the long-term safety and efficacy of the drug are
unknown. There is therefore an urgent unmet need to understand disease-promoting mechanisms for
development of optimal interventions. Despite many advances in understanding the role of mTORC1-dependent
pathways in LAM progression, the fundamental mechanisms underlying the female predominance of LAM
primarily are not understood. In the Multicenter International LAM Efficacy of Sirolimus (MILES) trial, lung
function declined five times more rapidly in premenopausal than postmenopausal patients, suggesting that
estrogen plays a major role in LAM progression. Considering the actions of estrogen may be mediated by
changes in sphingolipid metabolism, our hypothesis is that estrogen promotes sphingolipid metabolism in
TSC2-deficient cells, leading to abnormal LAM lung cell growth and emphysema-like destruction of lung
parenchyma and lung function decline. In Aim 1, we will use biochemical and single-cell multiome approaches
to determine the molecular mechanisms through which TSC2 inactivation and estrogen promote sphingolipid-
mediated cell survival. In Aim 2, we will determine the impact of pharmacologic suppression of ASAH1, S1PR1/3,
ERα/β, or PR, on E2-induced lung remodeling in vivo. We postulate that that the combined suppression of
sphingolipid signaling with Fingolimod, an S1PR1/3 modulator, or estrogen receptor inhibition with Faslodex or
a SERM Raloxifene, or PR suppression with Mifepristone, and Sirolimus will, unlike cytostatic treatments
involving Sirolimus alone, induce regression of E2-promoted lung remodeling and attenuate lung function decline.
In Aim 3, we will test the hypothesis that the combinatorial treatment with 17a, Fingolimod, Faslodex, Raloxifene,
or Mifepristone, plus Sirolimus will be well-tolerated and more effective than single agent in a uterine-specific
Tsc2 knockout mouse model that closely resembles the human LAM. We will utilize innovative, state-of-the-art
technology including single-cell multiome to identify estrogen/progesterone-regulated transcription factor
activation, epigenomic alterations, and non-invasive optical and MRI imaging. The significance of this project
is that it will reveal for the first time the combined roles of sphingolipid metabolism and E2 in LAM progression.
This study will have high impact because current therapies for LAM are cytostatic and limited to stabilizing lung
function. As Fingolimod and anti-hormonal compounds are already FDA approved for the treatment of multiple
sclerosis and breast cancer, these cell-based and preclinical studies could be rapidly translated into human
clinical trials for patients with LAM and other mTORC1 hyperactive diseases.

Public health relevance
Project Narrative: This proposal will investigate how estrogen and inactivation of the tuberous sclerosis complex (TSC) gene cause the often fatal and female-predominant lung disease, lymphangioleiomyomatosis (LAM). We have evidence that the effect of the TSC mutations is to alter the expression of an important lipid metabolite critical for LAM progression. In cells and mouse models, we will test the effects of Fingolimod, an FDA-approved inhibitor of the action of this metabolite, the estrogen receptor inhibitor Faslodex, progesterone receptor inhibitor Mifepristone, or Selective Estrogen Receptor Modulator (SERM) Raloxifene, on LAM with the ultimate goal of performing human clinical trials in LAM patients.